EFFECT OF ANTIHYPERTENSIVE THERAPY ON RENAL BLOOD FLOW--MR CINEANGIOGRAPHY

To determine whether a converting enzyme inhibitor calcium channel blocker, or combination of both will normalize renal blood flow in ADPKD patients.